Investigating the Role of PLIN2 in Senescence

PROJECT SUMMARY/ABSTRACT
Understanding the biological basis of aging-related diseases is becoming paramount as the global population
ages and the burden of chronic disease weighs on healthcare systems. Cellular senescence has emerged as a
unifying feature of multiple age-associated pathologies, having been identified as a significant player in
numerous cancers, neurodegenerative diseases, hepatic fibrosis and steatosis, and age associated muscle
dysfunction. Senescence is a state of cell cycle arrest that also features mitochondrial dysfunction, lipid
accumulation, and a highly inflammatory senescence-associated secretory phenotype (SASP). This SASP is
currently thought to be one of the primary causes of senescence-associated tissue dysfunction. The SASP,
consisting of cytokines/chemokines, growth factors, proteases, and lipid-derived eicosanoids, promotes chronic
inflammation and dysfunction in neighboring cells. To date, research in this area has mainly focused on
detrimental effects of secreted SASP proteins, leaving the lipid/eicosanoid contribution to SASP and
senescence largely unstudied.
Senescent cells characteristically accumulate lipid droplets (LDs), which have recently been identified as central
nodes in the inflammatory response and as sites for eicosanoid production. LD metabolism can either contribute
to or protect against inflammation depending on the composition of proteins residing on the LD surface. One
such protein, Perilipin 2 (PLIN2), has been shown to play pivotal roles in multiple inflammatory conditions and
can regulate the efflux of inflammatory lipids from the LD. My primary objective is to elucidate the mechanisms
by which LDs and LD proteins modulate senescence, which could allow for specific targeting of this inflammatory
process. My central hypothesis is that PLIN2 plays a key role in the initiation and maintenance of SASP
and senescence. We will test this hypothesis by establishing a mechanism by which PLIN2 interacts with
eicosanoid synthesizing enzymes in senescence and regulates eicosanoid release from the LD. Then we will
show that PLIN2 knockout in senescent cells in aged mice attenuates global inflammation, reduces the SASP in
senescent cells, and enhances healthspan of aged mice. No study to date has investigated a role for PLIN2 in
senescence. This proposal will lay the groundwork establishing PLIN2 and the LD as central to senescence and
SASP, thus unveiling a novel mechanism by which senescence contributes to aging.

Public health relevance
NARRATIVE The goal of this application is to elucidate the role of the lipid droplet and PLIN2 in the initiation and maintenance of the senescence phenotype. This work is significant as PLIN2 has clearly been shown to modulate inflammatory states but its ability to regulate the proinflammatory phenotype of senescence has yet to be established. By focusing on this novel niche in senescence, this proposal will lay the groundwork establishing PLIN2 and the LD as central to senescence and its associated inflammatory secretome, thus unveiling a novel mechanism by which senescence contributes to tissue dysfunction.